PHYSIOLOGIC EFFECTS OF POSITIONING ON PREMATURE INFANTS

The purpose of this study is to determine whether physical positioning can be used as an intervention to minimize physiological disturbance caused by NICU caregiving procedures in ill, preterm infants.